Patient-directed technology for non-pharmacologic management of cancer pain

PROJECT SUMMARY/ABSTRACT
Patients living with cancer commonly experience chronic pain, defined as pain lasting at least three months.
While cancer pain management has traditionally focused on pharmacologic therapies, particularly opioids, pain
experts, clinical guidelines, and patients living with cancer increasingly support the use of non-pharmacologic
therapies (including mind-body modalities such as distraction, mindfulness, and cognitive behavioral therapy) to
mitigate pain and potentially reduce pain medication needs. Virtual reality (VR), a rapidly evolving technology
that immerses the user in pleasant, virtual environments, has been shown to lower different forms of acute and
chronic pain syndromes, but has not been developed specifically to improve chronic cancer pain. Our long-term
goal is to develop and disseminate a patient-centered, patient-driven VR intervention that significantly improves
the chronic cancer pain experience. Towards this end, we propose a multi-phase project involving active patient
stakeholder input and an iterative design process that will achieve the following Specific Aims: Aim 1 – to identify
patient perceptions around chronic cancer pain experiences and management strategies; Aim 2 – to develop a
highly feasible, acceptable, usable, safe VR prototype enabling patient-directed management of cancer pain;
Aim 3 – to conduct a trial to assess prototype feasibility, acceptability, usability, and safety. Completion of this
project will lead towards development of a scalable VR intervention to mitigate pain that has potential to
dramatically improve quality of life and clinical outcomes in patients living with chronic cancer pain.

Public health relevance
PROJECT NARRATIVE Patients living with cancer commonly have chronic pain due to the disease or to cancer treatments. Virtual reality, a new technology that immerses the user in pleasant, diverting, and exciting virtual environments, may lower chronic cancer pain to improve quality of life and complement need for pain medications like opioids. We aim to learn from patients about the experience of cancer pain, develop a virtual reality prototype specific to cancer pain management, and test the feasibility and acceptability of this technology to improve the cancer pain experience.